Implementation of Innovative Treatment for Moral Injury Syndrome: A Hybrid Type 2 Study

Background: Moral injury syndrome (MIS) consists of the psychological and behavioral sequelae of experiences
that challenge moral, spiritual, or values related beliefs. Symptoms of MIS may include hopelessness,
helplessness, loss of previously held spiritual beliefs, struggle with a Higher Power, difficulty with forgiveness,
lack of meaning or purpose, reduced trust in self or others, or intractable guilt, shame or anger. Individuals
managing MIS are up to twice as likely as their peers to consider and attempt suicide, and derive less benefit
from psychotherapy. There are few evidence-based interventions for moral injury; one such intervention is a
manualized, group intervention called "Building Spiritual Strength (BSS)." In previous randomized controlled
trials BSS has been shown to reduce both symptoms of PTSD and spiritual distress. This clinical trial will be one
of the first to measure symptoms of MIS as a primary outcome. Hypotheses are: Hypothesis 1: Compared to
PCGT, BSS will significantly decrease symptoms of moral injury syndrome (primary effectiveness outcome).
Hypothesis 2: Compared to PCGT, BSS will significantly decrease symptoms of depression, decrease suicidal
ideation, and reduce functional impairment. (secondary effectiveness outcomes).
Significance: To date there are not standard procedures for assessing and treating MIS, so it is likely that
untreated MIS is contributing to poor outcomes, including suicides. Developing an implementation toolkit so
that BSS is widely available in VA facilities could reduce the impact of MIS on Veterans’ mental health.
Innovation and Impact: To date there have not been funded implementation studies on treatments for MIS in
Veterans, and very few VA facilities provide evidence-based care for MIS. This study can clear the way to
make evidence-based care for MIS more accessible in the VA system.
Specific Aims: 1.Conduct a mixed methods pre-implementation evaluation to identify barriers and
facilitators for BSS implementation at each site, and to develop local implementation strategies. Specific
implementation variables assessed, based on the Proctor and Evidence Based Quality Improvement (EBQI)
models include acceptability, appropriateness, and feasibility. Specific variables to be assessed will include a)
acceptability of BSS to stakeholders, b) available implementation resources, and c) organizational openness to
adding a new EBP.
2. Conduct a randomized controlled trial comparing BSS to Present Centered Group Therapy (PCGT) for
Veterans who score above cutoff (score >14) on the Moral Injury Outcomes Scale. Effectiveness and functional
outcomes will be informed by the psychospiritual developmental model of MIS.
3. Conduct a mixed methods post-implementation evaluation to compare outcomes across chaplaincy
managed vs. mental health managed BSS programs. Proctor20,21model outcomes will include adoption, fidelity,
penetration, and sustainability. Specific outcomes related to this framework include a) successful BSS
implementation, b) fidelity in implementation of BSS, c) provider awareness of, and willingness to refer to BSS,
and d) qualitative reports of intent to maintain the BSS program when the study is complete.
Methodology: This will be a type 2 hybrid study, combining pre- and post-implementation evaluations with a
randomized clinical trial at 4 culturally diverse VA sites.
Next Steps and Implementation: Data on barriers and facilitators will be used to develop a toolkit and
collaborate with our partners at the Office of Mental Health and Suicide Prevention and the National Chaplain
Service to develop a national dissemination plan for BSS. We will work with existing clinical staffing at our
study sites, so that those sites can continue to provide BSS services after the study. Furthermore, after
completing this study, BSS leaders will be qualified to train BSS leaders at other sites, creating resources for
training and national dissemination.

Public health relevance
Moral Injury Syndrome (MIS) affects up to 35-60% of Veterans managing combat-related PTSD; it results from experiences that challenge deeply held values or spiritual beliefs. Symptoms of MIS may include hopelessness, helplessness, loss of spiritual beliefs, difficulty with forgiveness, loss of meaning or purpose, reduced trust in self or others, or intractable guilt, shame or anger. Veterans managing MIS have difficulty responding to mental health treatment, and are at increased risk for suicide ideation or attempts. To date evidence-based interventions for MIS are not widely available in VA. This study will implement an evidence-based intervention for MIS in four VA facilities, collect data on the effectiveness of the intervention, and develop an implementation toolkit. This data will inform national dissemination in collaboration with the Office of Mental Health and Suicide Prevention and the National Chaplain Service.